MASPHL-NARMS Cooperative Agreement

PAR-20-124 NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic Resistance
Surveillance in Retail Food Specimens
Massachusetts State Public Health Laboratory
Abstract
The Massachusetts State Public Health Laboratory (MASPHL) is requesting funding from
PAR-20-124 NARMS Cooperative Agreement Program to Enhance and Strengthen
Antibiotic Resistance Surveillance in Retail Food Specimens in order to contribute to the
understanding of the burden of antibiotic resistant pathogens in retail meats in the food
supply. MA SPHL is committed to producing the highest quality results from the testing
performed at the lab and are using methods accredited to the ISO 17025 standard (or
equivalent), thereby assuring of the quality of the results generated.

Public health relevance
PAR-20-124 NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens Massachusetts State Public Health Laboratory Project Narrative MASPHL will participate in this project by purchasing the required 33 products per month from retail locations in Massachusetts. Products will be tested for a combination of analytes as described in the provided protocols for 2022. Confirmed isolates of representative organisms from required products will be sequenced and analyzed, with analysis results shared with FDA via GenomeTrakr by PulseNet certified analysts. Isolates will be sent to FDA NARMS for antimicrobial susceptibility testing along with hard copies of electronic log sheets. Isolates will be retained on-site, along with copies of the log sheets.